Improving CAR-T efficacy against solid tumors by expanding lymph node reservoirs of “stem-like” CAR-T cells

PROJECT SUMMARY/ABSTRACT
Immunotherapy using CAR-T cells has induced dramatic responses in hematological malignancies, but
extending this success to more common epithelial cancers, which cause the greatest mortality, has proved more
challenging. In a phase 1 trial we conducted, CAR-T cells targeting the tumor-associated antigen ROR1 induced
responses in patients with chronic lymphocytic leukemia but became terminally exhausted in breast and lung
cancer patients, indicating that strategies to preserve CAR-T function are needed to achieve efficacy in solid
tumors. Recent work has demonstrated that a subset of PD-1+Tcf1+ “precursor” exhausted cells (Tpex) is critical
for mediating successful tumor responses to immunotherapy. Tpex retain a stem-like capacity for self-renewal,
proliferation, and the ability to differentiate into effector-like cells. Interestingly, Tpex preferentially co-localize
with antigen-presenting cells (APCs) and reside in tumor-draining lymph nodes (tdLN), where they may be
protected from factors in tumors that drive terminal exhaustion, such as more chronic antigen stimulation, mTOR
activation, and hypoxia. Unlike conventional T cells, CAR-T cells are activated by intact antigen expressed on
tumor cells, not by peptide/MHC complexes expressed on both tumor cells and APCs. This design restricts CAR-
T activation exclusively to tumors, where preservation of stem-like qualities may be impaired relative to tdLNs.
To test this, we developed a Kras/p53 (KP) autochthonous model of ROR1+ lung cancer that recapitulates the
dysfunction of ROR1 CAR-T cells we observed in patients. Using this model, we found ROR1 CAR-T cells did
not accumulate in tdLNs and showed faster attrition of Tpex and terminal exhaustion in tumors compared to
tumor-specific T cells (TCR-T) that were cultured identically prior to infusion. Tcf1+ CAR-T cells showed greater
proliferative capacity, stem-like self-renewal, and tumor control compared to Tcf1- CAR-T cells, suggesting that
strategies to preserve Tcf1+ CAR-Ts could significantly improve efficacy. Interestingly, CAR-T cells in tdLNs
formed a small reservoir of “pre-exhausted” PD-1-Tcf1+ central memory cells that we could increase by
vaccination and that may be able to generate more polyfunctional effectors than Tpex, which are epigenetically
committed to producing hypofunctional effectors. We hypothesize that insufficient activation of CAR-T cells by
APCs in tdLNs impairs maintenance of stem-like Tpex reservoirs, resulting in less durable tumor control, and
that using vaccination to increase reserves of Tcf1+ CAR-T cells in LNs will overcome this barrier. In this proposal,
we will use the KP model to determine: 1) whether CAR-T are impaired in maintaining a stem-like Tcf1+ reservoir
relative to TCR-T cells and whether this is due to insufficient activation by APCs; and 2) whether activating CAR-
T cells with endogenous APCs in LNs via a novel vaccine platform will improve numbers of Tcf1+ CAR-T cells,
tumor control, and response to PD-L1 blockade. Our results will reveal whether CAR-T exhaustion in solid tumors
is driven in part by impaired Tpex formation and will evaluate a novel vaccine platform to overcome these defects
that can be translated to the clinic to enhance the efficacy of CAR-T cells in patients with solid tumors.

Public health relevance
PROJECT NARRATIVE CAR-T cell therapy has induced dramatic responses in hematological malignancies, representing one of the most remarkable therapeutic advances in the past decade, but efficacy in more common solid tumors has been limited by rapid dysfunction and poor persistence of tumor-infiltrating CAR-T cells. Successful tumor responses to immunotherapy are mediated by a subset of Tcf1+ T cells that resides in tumor-draining lymph nodes, where they retain the capacity to self-renew, proliferate, and continually differentiate into short-lived effector cells to sustain tumor killing. In this proposal, we will use a clinically relevant model of human lung cancer to investigate whether CAR-T cell activity is limited by inefficient formation of a Tcf1+ reservoir and whether this defect can be overcome using vaccination to expand lymph node reservoirs of Tcf1+ stem-like CAR-T cells, providing a strategy to enhance CAR-T cell efficacy that can be readily translated to the clinic to improve patient outcomes.